VITAMIN E DEFICIENCY, CHRONIC CHOLESTASIS, AND MALABSORPTION SYNDROME

We propose to determine the optimal dose of supplementary oral vitamin E for infants with cholestasis and to determine the critical age for initiation of parenteral vitamin E therapy in deficient young children who are unresponsive to oral vitamin E therapy.